Genomic and Circulating Predictors of PAH response

Pulmonary arterial hypertension (PAH) is a relentless disease characterized by vascular obliteration, right heart
failure and death. Although there are ten FDA-approved therapies in three classes for PAH, none is curative
and approximately 40% of patients are dead within 5 years of diagnosis. There is no established approach to
identify patients who will respond to a specific therapy. The goals of this proposal are to improve outcomes in
PAH using precision medicine concepts through an advanced genetics and “Omics” techniques. In unselected
PAH patients, there are two subsets with striking responses to therapy. One is a small subset that has a
marked reduction in PAH acutely in response to vasodilators and a dramatic long-term clinical response to
calcium channel blocker (CCB) therapy. We previously published that RNA expression patterns and DNA
variants in idiopathic PAH patients successfully identify patients that respond to CCB therapy. The second
subset is patients that have marked improvement with parenteral prostacyclin (PP) therapy. Presently, there is
little insight on how to select among the three FDA-approved PAH drug classes aside from clinical metrics of
disease severity and little understanding of how PP therapy improves PAH. The first funding cycle of this grant
has begun to address this unmet need by focusing on predicting responses to PP therapy. We have found two
potential genetic associations with prostacyclin response, one is a polygenic risk score and the other is a
variant in the complement 5 (C5) gene identified through a genome wide association study. Additionally, we
prospectively enrolled 40 patients with PAH initiating PP to detect molecular predictors of prostacyclin
response. In our early analysis, we have found changes in T cell phenotype in patients after PP, suggesting a
more “tolerant” immune phenotype after PP. Others have published an important role for T cells in promotion of
PAH, but the effect of PP therapy on T cell populations is unknown. This data was supported by a similar
pattern of cytokine amelioration with PP (reduced IL-17A, IL-5). We found that IFN concentration at initiation
could predict transplant-free survival, suggesting that these cytokines may be used to personalize treatment for
PAH. We and others have extensively studied metabolic dysfunction in PAH, but the reasons underlying this
phenomenon remain elusive. Here we found that in PAH patients requiring PP, plasma glucose directly
correlated with IL-17A levels in the plasma, suggesting a potential link between metabolic disease and immune
cell function in PAH. We hypothesize that immune phenotypes govern prostacyclin responses and are
associated with metabolic changes in PAH. We propose the following specific aims to test this hypothesis: (1)
Test the hypothesis that genomic phenotypes of prostacyclin response are common in all PAH subtypes, and
are associated with poorer transplant-free survival in subjects treated with prostacyclins. (2) Test the
hypothesis that inflammatory phenotype defines PAH prostacyclin response. (3) Test the hypothesis that PAH
immune phenotypes are associated with metabolic dysfunction and ameliorated with prostacyclin therapy.

Public health relevance
NARRATIVE Pulmonary arterial hypertension is a relentless disease characterized by vascular obliteration, right heart failure and death; approximately 40% of patients are dead within 5 years of diagnosis. This grant aims to use advanced genetic and Omic techniques to select patients most likely to benefit from prostacyclin therapy, the most potent therapy available with a portion of patients having marked improvement. The long term goal is to correctly match a patients unique biology to the appropriate therapy in PAH, thereby improving outcomes in this highly morbid disease.